Learning and Discovery in Experimental Environmental Health Science: On the Path from Data to Knowledge

To achieve a healthy society, America needs both highly trained health professionals and a science-literate
public. The development of both begins during K-12 education. Within the NIH, the SEPA program provides the
principal means to influence pre-college science education. Our application builds on current infrastructure,which
provides ca. 1700 high school students per year, many of them from underrepresented groups, with authentic
scientific experiences based on experiment modules that utilize live organisms as biomedical models. Students
investigate the impacts of environmental/life-style chemicals on fundamental biological processes. Inthe process,
ca. 20 pre-service teachers per year learn to teach with an inquiry-based approach. Moving forward,the proposed
SEPA program will i) engage in-service and pre-service teachers and students with an in-depth introduction to
the scientific method and its components that is closely linked to the conduct of the experiment modules. A major
focus will involve analytical applications of data science that emerge after aggregating large amounts of data
submitted by students to a computational portal and data repository. Complementing this novelemphasis, ii)
student experimentation will be placed within a context of science and society, called environmental health civics
– a history of environmental chemicals in relation to governmental regulation and chemical toxicityresearch.
Attention will be directed toward environmental justice, particularly issues which effect Milwaukee youth,
including lead (Pb) poisoning, through the use of a powerful on-line environmental health mapping program from
the EPA. Experiment modules and special student conferences will further develop this area. Both i) and ii) will
be fully aligned with the Next Generation Science Standards. In addition, we will iii) provide new ways for early
career teachers to implement our program as they transition from pre-service status to maturein-service teachers.
Finally, iv) we will transfer our program to an on-line format and partner with other institutions to expand the
reach of our pre-service teacher program. Content goals will be merged with our objective to offer large numbers
of minority and economically disadvantaged students research experiences withour modules. Our Specific Aims
are to 1. Introduce in-service and early career teachers to the principles of data and data science in relation to
our environmental health experiment modules. 2. Collaborate with the University of Wisconsin-Milwaukee, UW-
Stevens Point science teacher education programs to certify 100 pre-service teachers in the principles and
practice of scientific experimentation and communication. 3. Provide 8,500 high school students with a)
experiences in doing data and data science-focused scientific research, and b) an understanding of the
importance of chemical toxicology, including a focuson environmental justice. 4. Work with the Milwaukee Public
School System and other regional schools to provide large numbers of low income and underrepresented
minority students with research experiences. 5. Develop a robust on-line version of our program. 6. Conduct a
thorough evaluation of the entire project. (Underline links parent and supplement proposals)

Public health relevance
The University of Wisconsin-Stevens Point in collaboration with the University of Wisconsin-Milwaukee SEPA program will prepare pre-service, early career, and in-service teachers in north-central Wisconsin to provide large numbers of students, particularly disadvantaged and underrepresented rural students, with authentic research experiences using novel biomedical model organisms that link biological science concepts with societally relevant problems of environmental health/chemical toxicity. To become adept at doing and analyzing experiments, students will develop a solid comprehension of the elements of the scientific method. Conducting research within a framework of understanding the history of environmental chemicals and its implications for environmental justice in rural settings, students will gain insight into relationships between science and society and, in the process, be stimulated to enter biomedical STEM fields.